Harnessing the gut microbiome to detect and quantify glycans

Project Summary
Detecting various compositionally similar but structurally distinct glycans present in heterogenous mixtures has
traditionally been challenging due to the limitations facing current glycomics approaches. These limitations have
hindered our understanding of the availability and abundance of individual glycans simultaneously present in the
mammalian intestine, which contains complex mixtures of microbial, mammalian, and plant-derived oligo- and
polysaccharides. Moreover, intestinal glycans are a primary driver of gut microbiome composition and
metabolism, which represents an increasingly important human health determinant, and necessitates a deep
understanding of the glycomic-microbial interface to identify important biological interactions and putatively
develop glycan-derived therapeutics to target specific microbial activities. Therefore, new tools are necessary to
detect and measure the relative abundance of individual glycan substrates present in the heterogeneous
mixtures prepared from biological sources such as mammalian intestinal contents. We have harnessed the
glycan detection machinery employed by dominant members of the gut microbiota to detect, measure and isolate
individual glycan substrates present in heterogenous mixtures extracted from the mammalian intestine. Herein,
we demonstrate robust, specific, and scalable approaches by which engineered microbes report the presence
of individual glycan substrates with incredible sensitivity. Furthermore, we demonstrate that this approach can
accurately measure the abundance of individual glycans present in mixtures across wide linear ranges and that
the specificity and sensitivity of these measurements can be tuned by modifying particular microbial glycan
utilization genes. Finally, we demonstrate that microbially-encoded glycan-binding proteins can be used to isolate
individual target glycans from mixtures for downstream compositional and structural determination. We propose
to 1.) develop arrayed libraries of distinct gut microbial species, each engineered to report the presence of unique
target glycans, 2.) develop a rapid glycan isolation pipeline to purify individual substrates of interest for
downstream structural and functional characterization, and 3.) develop genetically modified microbial strains with
enhanced sensitivity or target specificity. In addition to offering a rapid and inexpensive alternative to quantifying
known glycans, we believe that further development of these tools will reveal the presence and abundance of
previously undetectable glycans and dramatically enhance our understanding of the interactions between gut
microbes and their mammalian hosts.

Public health relevance
Project Narrative We have harnessed the glycan detection machinery possessed by members of the human gut microbiome to develop a new toolkit to complement current glycomics approaches. We demonstrate how these tools can be implemented to surveille crude biological samples for structurally diverse plant, animal, and microbial glycans and subsequently measure the relative abundance of individual substrates present in heterogeneous glycan mixtures. Finally, we propose expand the capacity, specificity, and sensitivity of these tools to develop new affinity purification methods that can rapidly isolate individual glycans from a mixture for downstream structural analysis.